Personalizing genetic test results management and outcomes after diagnosis of cancer: the Georgia-California SEER Genelink Study

Abstract: The rapid diffusion of genetic testing across adult cancer diagnoses is a unique opportunity to
personalize cancer treatment and prevention at the population level. Germline genetic testing guidelines have
broadened to encompass nearly all patients with breast, ovarian and pancreatic cancer; all patients with
advanced prostate cancer; and many patients with colorectal, endometrial, and other cancer types. The
growing use of genetic testing is driving the development of precision oncology: a new paradigm for
personalizing prevention and treatment based on genetic testing results in addition to or instead of traditionally-
measured tumor features. Increasingly, an inherited pathogenic variant in a specific gene serves as an
essential common thread that connects diverse cancer diagnoses and enables genetically-targeted cancer
therapy. However, we know virtually nothing about how genetic test results are managed across cancer types.
We pioneered the Georgia-California (GACA) Genetic Testing Linkage Initiative, linking industry-provided
genetic testing data to SEER registry records for all adults diagnosed with cancer in Georgia and California
from 2013-19. We found that genetic testing across cancer conditions has increased but rates are too low
relative to clinical recommendations. Our foundational work underscores the urgent need for research about
how well genetic testing results are broadly integrated into the management of cancer. We are now completing
the next phase of the GACA Genetic Testing Linkage Initiative: merging SEER data for all adults diagnosed
with cancer in Georgia or California from 2013-21 (N=1,826,000), with an update planned for cancers
diagnosed in 2022-23 (N=456,000), to genetic results through 2025. We will use this unique, population-based
data infrastructure to determine whether genetic testing results management is effectively personalized across
common cancers with high testing rates. We will also examine cancer mortality by genetic testing results to
inform communication about prognosis and personalized treatment. Our hypotheses are as follows:
Extensiveness of surgery (e.g., organ preservation vs. removal) is well-personalized: it is strongly associated
with clinical indications derived from tumor features, host factors and actionable genetic results, but not with
non-actionable genetic results, socioeconomic or healthcare system factors. Receipt of chemotherapy and
genetically targeted systemic therapies (immune checkpoint inhibitors and poly(ADP-ribose) polymerase
inhibitors) is well-personalized: these treatments are strongly associated with clinical indications and actionable
genetic results, but not with non-actionable genetic results, socioeconomic or healthcare system factors.
Among cancer patients treated with systemic therapies, patients with PVs have lower cancer-specific mortality,
controlling for tumor features, treatments, comorbidities, socioeconomic and healthcare system factors.

Public health relevance
Project Narrative: The growing use of genetic testing across adult cancer diagnoses is driving the development of precision oncology: a new paradigm for personalizing cancer treatment and prevention based on genetic testing results. We pioneered the Georgia-California Genetic Testing Linkage Initiative, which linked industry-provided germline genetic testing data to Surveillance, Epidemiology and End Results program cancer registry records, and are now markedly expanding the initiative to include all adults diagnosed with cancer in Georgia and California from 2013-23 and genetic testing results through 2025. We will use this unique data infrastructure to determine whether the management of genetic testing results is effectively personalized to patient clinical factors and whether cancer mortality varies by genetic testing results, across cancer types.